Recombinant E-NTPDase for shock

SUMMARY
Inflammation after ischemia and reperfusion injury secondary to hemorrhagic shock is responsible for
significant mortality and morbidity in the United States. Available intravenous fluids administered at the incident
scene to treat hypovolemic shock do not completely prevent ischemia and reperfusion injury. Re-initiation of
blood flow causes activation of several inflammatory mediators, such as cytokines, selectins and other molecules
that rapidly mobilize the inflammatory response with subsequent multiple organ failure. The goal of the proposed
project is to prevent or reduce the deleterious effects of ischemic damage following resuscitation by using a
soluble recombinant human ectonucleoside triphosphate diphosphohydrolase (E-NTPDase) in conjunction with
intravenous fluids in patients with hemorrhagic shock. The approach is based on the well-documented
physiological protective role of E-NTPDases in protecting against ischemia-reperfusion injury. Our preliminary
data confirm that the endogenous E-NTPDase CD39 and the exogenously administered E-NTPDase mimic
apyrase both prevent organ injury in a well-accepted mouse model of fixed blood pressure shock. We have
synthesized a novel, highly potent E-NTPDase, hENTPD3-ECD, which we will test for efficacy in preventing
organ injury following trauma and hemorrhagic shock. The specific aim of this proposal is to assess the effect of
hENTPD3-ECD on organ injury in hemorrhagic shock. A dose-escalation study will be conducted with hENTPD3-
ECD in mice subjected to a combined insult of laparotomy (trauma) and hemorrhagic shock. These studies will
establish the effective dose of hENTPD3-ECD in protecting against organ injury in trauma and hemorrhagic
shock. Outcomes reported will be lung, gut, kidney, liver, and muscle injury, and red blood cell injury and immune
function. This proposal advances new therapeutic applications to control and/or alleviate ischemia/reperfusion
injury during and following resuscitation from shock.

Public health relevance
NARRATIVE Hemorrhagic shock resulting from trauma and other insults is responsible for significant morbidity and mortality in the United States. In the proposed studies, we will test a new molecule we synthesized, hENTPD3- ECD, which targets protective mechanisms in the body, for efficacy in protecting against organ injury in patients with hemorrhagic shock. The long-term goal is to develop hENTPD3-ECD as a safe and effective therapeutic intervention for hemorrhagic shock patients.